SLEEP AND FRONTAL LOBE FUNCTION IN REHAB FROM STROKE AND TRAUMATIC BRAIN INJURY

Little is known about prevalence & consequence of sleep disturbance of traumatic brain injury (TBI) & stroke populations. It is known that these patients often demonstrate signs of inattentiveness, memory difficulties and easy fatiguability which are commonly associated with sleep disturbance in uninjured populations. The proposed protocol will precisely characterize sleep of a representative sample of TBI & stroke patients, as well as correlating these findings with brain structure as delineated through SPECT & formal neurophychological evaluation.